Enhancing adult-born neurons to restore brain functions in Alzheimer's disease

Project Summary
Patients with Alzheimer’s disease (AD) exhibit progressive memory loss, depression, and anxiety,
accompanied by impaired adult hippocampal neurogenesis (AHN). Although young adult-born neurons (ABNs)
have been shown to play an important role in memory and emotion processing under physiological conditions,
their function and therapeutic potential in degenerated AD brains remain largely undefined. A long-standing
question has been centering on whether AHN could be enhanced in otherwise impaired AD brains to restore
cognitive and affective functions. Our recent study showed that stimulating hypothalamic supramammillary
nucleus (SuM) exerts robust neurogenic effects in healthy wild-type (WT) mice. Specifically, chronic patterned
optogenetic stimulation of SuM leads to increased production of behaviorally-relevant ABNs with enhanced
developmental properties. Importantly, acute chemogenetic activation of these SuM-enhanced ABNs improves
memory performance and reduces anxiety-like behavior. We further tested this strategy in 5xFAD mice. Strikingly,
patterned SuM stimulation restores the number and developmental properties of ABNs and acute chemogenetic
activation of a small population of these SuM-enhanced ABNs (~500 ABNs/DG, <0.05% total granule cells/DG)
is sufficient to restore memory and reduce anxiety/depression-like behaviors in AD mice. These findings highlight
the therapeutic potential of enhanced ABNs (number, quality, and activity) in functional restoration in AD. Building
upon these findings, we propose the following aims to decipher the mechanisms underlying these beneficial
effects mediated by activation of SuM-enhanced ABNs using two complementary AD mouse models. Aim 1 will
determine the functional properties of SuM-enhanced ABNs and the molecular regulators underlying SuM-
mediated enhancement of neurogenesis in AD mice. Aim 2 will determine activity-dependent contribution of
SuM-enhanced ABNs to local hippocampal circuit and brain-wide network dynamics in AD mice. Aim 3 will
determine the effects of SuM-enhanced ABN activation on microglia properties, AD pathology, and hippocampal
function in AD mice.

Public health relevance
Project Narrative Although young adult-born neurons (ABNs) have been shown to play an important role in memory and emotion processing under physiological conditions, their function and therapeutic potential in degenerated AD brains remain largely undefined. Our recent study showed activation of a small population of SuM-enhanced ABNs is sufficient to restore memory and reduce anxiety/depression-like behaviors in AD mice. This proposal aims to decipher the mechanisms underlying these beneficial effects using two complementary AD mouse models.